Enhancing Physical Activity Adoption and Maintenance in Adults with Obesity by Understanding Motivation for Exercise: A Mixed Methods Research Design

PROJECT SUMMARY/ABSTRACT
Physical activity (PA) is one of the best predictors of sustained weight loss and current guidelines recommend
high levels of PA to prevent weight regain after weight loss. However, long-term adherence to PA is generally
poor when adults with overweight/obesity are provided an exercise prescription consistent with current
guidelines. Thus, it is essential to evaluate novel strategies to enhance adoption and maintenance of PA in adults
with overweight/obesity. The overall goal of this mentored F32 application is to use mixed methods research to
optimize an innovative, theoretically based PA intervention designed to enhance motivation for exercise in adults
with overweight/obesity. Specifically, quantitative data (Aim 1) will be integrated with qualitative data (Aim 2) to
optimize an intervention designed to enhance MOtiVation for Exercise (MOVE) in adults with overweight/obesity
(Aim 3). In Aim 1, a latent transition analysis will be used to examine longitudinal measures of motivation for
exercise and objective PA data collected in 170 adults enrolled in a recently completed behavioral weight loss
trial (R01DK097266). In Aim 2, adults from an ongoing behavioral weight loss trial (R01DK111622) will receive
the MOVE intervention and participate in focus groups to explore how participants experience MOVE. In Aim 3,
quantitative and qualitative results will be integrated to optimize MOVE. The applicant, Dr. Danielle Ostendorf,
received graduate training in chronic disease epidemiology, clinical trial management, and person-centered
analytical approaches including latent profile analysis. Dr. Ostendorf’s long-term goal is to develop an
independent research program that focuses on the prevention and treatment of chronic diseases, including
obesity, by improving strategies to increase PA. To build upon her graduate training and expand her scientific
skillset, Dr. Ostendorf and her mentorship team have developed a comprehensive training plan. Dr. Ostendorf’s
primary training objectives include obtaining training in: (1) additional direct clinical research experience, (2)
behavior change theory and strategies, (3) latent transition analysis, a longitudinal extension of latent profile
analysis, (4) qualitative data analysis and mixed methods research, and (5) strengthening granstmanship,
publishing, and professional development skills. This research and training will take place at the University of
Colorado Anschutz Medical Campus, an exceptional environment that offers endless world-class opportunities
for Dr. Ostendorf to gain valuable skills and experiences that will foster her development as an independent
researcher. Successful completion of this proposal will result in several first-authored publications and will
generate critical preliminary data needed to support a competitive K01 application. This F32 proposal, with its
focus on expanding Dr. Ostendorf’s expertise in advanced statistical methods and development of new research
skills in mixed methods approaches, will serve as both a superb training opportunity and as an original and
meaningful scientific contribution to propel Dr. Ostendorf’s career forward as an independent investigator.

Public health relevance
PROJECT NARRATIVE The limited success of our current approaches to increase adoption and maintenance of physical activity in adults with overweight and obesity is a substantial barrier to effectively address the current obesity epidemic. This mentored F32 application addresses the significant public health issue of obesity and associated risk of major chronic diseases by using mixed methods research to optimize an innovative, theoretically based physical activity intervention designed to enhance motivation for exercise in adults with overweight and obesity. The proposed research is relevant to public health because it will provide important data to aid in the development of more effective physical activity programs for the large number of U.S. adults who struggle with obesity and its adverse health consequences.